Improving Health in Rheumatic Disease (IMHeaRD)

Project Summary – Methodologic Core
Addressing racial disparities in rheumatic diseases as complex as systemic lupus erythematosus and systemic
sclerosis requires interdisciplinary approaches that involve strong methodological components. The overarching
objectives of the CCCR Methodologic Core are to enhance the quality of research conducted by investigators in
the CCCR Research Community and to provide leadership on investigations relevant to minority health in
rheumatic diseases. To achieve these objectives within the CCCR, the Methodologic Core has 4 aims: 1) provide
quantitative guidance to the CCCR Research Community; 2) conduct research to develop novel biostatistics
methods; 3) participate in educational development of clinical and translational investigators; and 4) serve as
liaisons between the CCCR Research Community and other quantitative experts. The Core is comprised of four
PhD faculty with expertise in biostatistics, bioinformatics, and epidemiology, all of whom have a strong track
record of collaboration with rheumatologists, clinically-relevant methods development, and education. Through
interactions with our CTSA program and other important resources, the Core will also be able to leverage
additional expertise as needed. By achieving these aims through innovative techniques, the Methodologic Core
will help continue to ensure that MUSC is a leading entity in rheumatologic research.